Biomaterial scaffold-assisted drug delivery to modulate acute graft-versus-host-disease

PROJECT SUMMARY
The objective of this fellowship application is to develop a minimally invasive injectable biomaterial-based drug
delivery depot to enhance regulatory T cells (Treg) as a means to promote durable disease control in allogeneic
hematopoietic stem cell transplantation (HSCT)-associated acute graft-versus-host disease (aGVHD). Donor
Treg in HSCT grafts are widely recognized as the primary suppressors of recipient-reactive pathogenic effector
donor T cells. However, Treg are often insufficiently functional and/or display abnormal levels of inflammation-
induced instability. For example, when exposed to the inflammatory milieu in aGvHD, Treg may lose forkhead
box P3 (FoxP3) expression, essential for immunoregulatory function, and transform into pathogenic T cells
which can lead to enhanced inflammation in aGVHD. Here, the project will demonstrate the expansion and
stabilization of donor Treg via an injectable biomaterial that releases, in a sustained and localized fashion, a Treg
immunomodulatory agent. The project will develop and validate the Treg-modulating biomaterial as a
therapeutic option for aGVHD. Aim 1 will develop the biomaterial and characterize the efficacy of the Treg
modulating agent in post-HSCT aGVHD-affected mice. Aim 2, will assess durability and validate the
mechanism of action of Treg in mitigated aGVHD. The immediate results of this project will assess feasibility of
promoting Treg stability to improve outcomes in a well-established aGVHD mouse model. If successful, in the
longer term, the project will pave the way for a new approach to treat aGVHD and advance NHLBI's mission of
developing new therapeutics for blood disorders. The proposed training, guided by an expert mentorship team,
will enrich the applicant's knowledge and skills in biomaterials and drug delivery, flow cytometry and cell
sorting and histomorphometry and imaging techniques. Gaining expertise and research competency in the
subject matter through a quantitative methods-based training approach will support the development of the
applicant’s scientific knowledge towards a career as an independent researcher.

Public health relevance
PROJECT NARRATIVE Acute graft-versus-host disease (aGVHD) is a life-threatening immunological complication of allogeneic hematopoietic stem cell transplantation (HSCT). The project will develop a novel approach for delivering immune modulating agents following HSCT to expand and restore aGVHD-protective immune cells called Treg, collecting critical evidence of efficacy and mechanism of action in a mouse model of aGVHD.